Leadership, Planning and Evaluation

ABSTRACT
Eight individuals serve as Senior Leaders of the Memorial Sloan Kettering Cancer Center (MSK). Selwyn M.
Vickers, MD, FACS, MSK’s President and Chief Executive Officer, is the Director of this NCI-supported
Comprehensive Cancer Center. Physician-scientist Dr. Charles Rudin, MD, PhD serves as the Deputy Director
of the Cancer Center. Dr. Vickers works with MSK’s Board of Governing Trustees to provide stable governance
and financial oversight of MSK, and together with Dr. Rudin and Anaeze Offodile II, MD, MPH, MSK’s Chief
Strategy Officer, Dr. Vickers sets the strategic vision for the Cancer Center, ensuring that the cancer-focused
mission of the Center is relevant to the Center’s catchment area and fosters outreach to its population. Lisa
DeAngelis, MD is MSK’s Chief Physician Executive; in this role, Dr. DeAngelis oversees and guides all human
subjects research, primarily conducted within the clinical and population-based research programs, and sets
standards for the infrastructure to support the clinical research review and monitoring, and data management.
She also ensures that training for clinicians and biomedical professionals meets the highest standards. Joan
Massagué, PhD is MSK’s Chief Scientific Officer and the Director of the Sloan Kettering Institute. In his role he
oversees the non-clinical research programs and establishes standards for recruitment and retention of
outstanding laboratory-based scientists. Dr. Massagué oversees the core facilities of the Center and manages
the research budget to provide cutting-edge scientific support for the Center members. He also oversees the
training programs for pre- and postgraduate laboratory researchers. Colin Begg, PhD is Associate Director for
Population Sciences; Paul Sabbatini, MD is Associate Director for Clinical Research; Christine Iacobuzio-
Donahue, MD, PhD, is Associate Director for Translational Science; and Luis Parada, PhD is Associate
Director for Basic Science. The Associate Directors facilitate transdisciplinary research among the basic,
bridge, clinical and population science programs and provide a conduit for bottom-up communication from the
Program Leaders/Members to the Senior Leadership team.
In overseeing the Cancer Center activities, the Senior Leadership relies on the counsel of outside advisors,
represented by its Board of Scientific Consultants (BSC), the guidance of its Board of Governing Trustees, as
well as many internal planning processes to support the planning and evaluation of the research programs and
core facilities at the Center. MSK has used the guidance it has received to develop and execute its initiatives
for research, clinical expansion, and community engagement. During the past six years, the BSC has reviewed
the research in the programs as well as MSK’s Community Outreach and Engagement and scientific education
and training (CRCE) programming. BSC members review with Senior Leadership evolving technologies that
support cancer research and advise on core service offerings. The BSC has also reviewed newly recruited
investigators and the training programs that bring outstanding students to MSK’s laboratories. The
recommendations made by the BSC and other planning groups have led to strategic program planning, new
faculty recruitments, shared resource development, and facility expansions.